HIVIG MATERNAL FETAL TRANSMISSION IN PREGNANT WOMEN AND NEWBORNS

To evaluate the effect of polyclonal HIV immune globulin in the prevention of perinatal HIV transmission if given in combination with antepartum, intrapartum (mother) and postpartum (infant) zidovudine, beginning at 20-30 wks. gestation at monthly intervals. It is anticipated that provision of antiviral antibody in the HIV-infected pregnant woman and the newborn within 12 hours of delivery may neutralize circulating infections HIV, and thereby presumably re- duce or prevent transplacental and/or peripartum HIV infection of fetus/infant.